Investigations of Dementia in Parkinson Disease

ABSTRACT This project focuses on dementia in Parkinson disease (PD), one of the Alzheimer Disease Related Dementias. PD produces progressive motor and cognitive impairments leading to dementia in ~75% of patients after 10 years. Development of therapies to slow PD progression requires validated biomarkers of pathologic processes and that predict progression. Such biomarkers could reflect local, regional pathology or disruption of widely distributed networks that cause behavioral deficits. This project focuses on cross-sectional and longitudinal relationships among proteinopathy, cholinergic and noradrenergic deficits, disruption of functional connectivity networks and behavior. We will build upon our findings in a single site (to maximize rigorous quality control and retention of participants) longitudinal cohort of 299 people with PD and controls to extend and expand a multimodal approach to determine the time course of biomarker changes that correspond with and predict cognitive decline in PD. We have the potential to provide in vivo neuroimaging and CSF biomarkers of pathology and pathophysiology that could independently, or in combination, predict clinical manifestations in PD. We will combine PiB (an Aβ amyloid imaging agent), VAT (a vesicular cholinergic transport ligand), and MRB (a norepinephrine transport ligand) PET, CSF protein levels and resting state functional connectivity analyses (FC using advanced analysis methods) measures of pathophysiology with sophisticated behavioral measures focusing on cognition and postmortem brain analyses including quantification of pathologic proteins. We will determine the relationships between PET biomarkers and CSF proteinopathy, and compare these to clinical manifestations. FC, as a measure of brain function, will link brain pathology and neurochemistry with the associated clinical manifestations. In this manner, we will develop a strong mechanistic understanding of changes in these neuroimaging and CSF biomarkers and how this relates to cognitive decline and dementia onset in PD. This project holds great promise for identifying pathophysiological biomarkers for prediction of PD progression, patient stratification for clinical trials, and evaluation of new treatments.

Public health relevance
PROJECT NARRATIVE Parkinson disease (PD) is a progressive neurologic degenerative disease affecting nearly one million people in North America. Individuals with PD have very high risk for development of dementia that adds substantial morbidity, mortality and economic burden to patients, families and society. This multimodal study will establish the time course of changes in a variety of biomarkers that may help to understand the mechanisms underlying cognitive impairment and are critical to design studies to slow PD progression and identify targets of engagement for new therapies. Our single site study permits greater rigorous quality control and follow up that complement multicenter cohorts.